Targeting ATG4B to Treat Glioblastoma

PROJECT SUMMARY
Glioblastoma (GBM) is among the most common and malignant tumor in the central nervous system with
an extremely poor prognosis. New treatments for this disease are desperately needed and the protease
ATG4B is a new potential target to reduce GBM tumorgenicity and prolong patient life. Based on strong
preliminary results, we propose to create new ATG4B inhibitors through a collaborative and iterative
process. Our collaborative workflow involves a) optimization of a commercial compound (NSC185058)
with poor potency and drug like characteristics guided by in vitro potency and selectivity, b) evaluation of
blood brain barrier and metabolic performance, and lastly, c) in vivo efficacy investigations combining our
best candidates with radiotherapy and temozolomide. This high risk, high reward project will add validation
to ATG4B as a prime target for GBM treatment and provide new Northwestern-based drug compounds to
combat this dreaded disease.

Public health relevance
PROJECT NARRATIVE In malignant glioblastoma (GBM), autophagy-mediated intracellular recycling sustains tumor metabolism, growth and survival favors tumor growth and progression and also provides a mechanism for GBM cell to survive and acquire resistance to therapeutic treatments such as radiation and chemotherapies. In this project, we propose to create and characterize new inhibitors for ATG4B, a key autophagy regulator for assessing their anti-GBM activity in combination with standard care therapy for GBM through a collaborative and iterative process.